Functional genetic variants in substance use disorders

PROJECT SUMMARY
The long-term goal of this study is to identify functional genetic variants that are associated with
SUDs, and thereby contribute to understanding the mechanisms underlying these devastating
disorders. Our overall objectives are to (i) design and implement a series of experimental methods
to assess the impact of genetic variants relevant to SUDs and related traits and computational
models to predict the impact of additional variants, and (ii) establish a statistical genetics
framework to more effectively identify additional genes that contribute to the disorders. This
proposal builds upon our previous studies on the role of genomic variation in gene regulation and
will generate new data to combine with existing multi-omics data and modeling. We propose the
following Specific Aims: 1. Identify functional genetic variants that contribute to the risk for
substance use disorders and related phenotypes by affecting gene regulation, using a
series of high-throughput reporter assays to evaluate the impact of tens of thousands of non-
coding variations in enhancers, promoters and 3’UTRs on gene expression in eight cell lines
representing four major cell types in brain (neurons, microglia, astrocytes and oligodendrocytes).
Variants with a modest association with substance use disorders and related traits will be selected
from the GWAS catalog and experiments underway. Data on the initial large sets of variants will
be used to predict, using machine learning approaches, the functional impact of additional
regulatory variants. A large subset of the variants predicted to be functional will then be tested
with follow-up HTRAs, and the predictive models refined based upon the data. 2. Identify genes
whose expression changes contribute to the risk for SUDs. We will use Mendelian
Randomization-based methods based on the data derived from Aim 1 plus GWAS data from the
PGC and other large consortia to identify causal genes whose expression changes in specific cell
types contribute to SUD-related phenotypes. Upon completion of these studies, we will have
created a unique, accessible resource of SUD-associated genetic variants that regulate target
gene expression in specific brain cell types. These genes can serve as high priority candidates
for future functional and animal-based studies.

Public health relevance
Project Narrative The goal of this project is to design and implement a set of high-throughput reporter assays and computational methods for prioritizing causal genetic variants and identifying driver genes that contribute to the risk for substance use disorders. This is directly relevant to the missions of NIH to improve the capability of diagnosis, treatment, and prevention of these devastating disorders. Similar strategies can be used to study the etiology of other complex diseases.